Healthy Americas: All of Us Research Program

Healthy Americas: All of Us Research Program
Overview: Healthy Americas: All of Us Research Program is a national effort to support full engagement of American communities in the All of Us Research Program. The effort works to inform, motivate, and support enrollment and ongoing engagement through one- to-one support for prospective and current participants. The Healthy Americas program also advances use of the All of Us dataset to address knowledge gaps and expand health research and personalized and precision medicine through support of research teams studying a broad range of health conditions. The effort is critical to advancing discovery, shaping the future of medicine.
NIH Spending Categories Neurosciences
Precision Medicine
Project Terms
All of Us Research Program Communities
Community Involvement Community Organizations Patient Engagement

Public health relevance
Our work advising and supporting the All of Us Research Program’s efforts to enroll and retain participants will contribute to having more data available for groundbreaking research to help better understand and improve public health in the United States. Our work mentoring and training biomedical scientists to conduct studies with All of Us data will develop more scientists prepared to leverage large scale data and peer-reviewed research to accelerate health research and medical breakthroughs, enabling individualized prevention, treatment, and care for all of us.